Progressing integration of in vitro topical formulation characterisation, release and permeation data to the next level - PBPK based extrapolation to bioequivalence assessment in virtual populations

Project Summary/ Abstract
Physiologically Based Pharmacokinetic (PBPK) modelling has become an important part of
the drug development process, both for novel and generic drug products. For the later, the
USFDA supports the use of modelling and simulation for establishing (virtual) bioequivalence
between reference and test products. Incorporation of PBPK modelling can increase
confidence in in vitro data and help to reduce or eliminate the need for clinical trials, thus
accelerating approval of affordable drug products. The overarching aim of this grant proposal
is to progress integration of in vitro data to PBPK models by enhancing the MPML MechDermA
model, defining best practices for in vitro data usage, and analysing and re-considering study
protocols utilised to generate the data. Aim 1 is to collate and make publically available an
extensive database of skin permeability data that can be used to verify and/or optimize PBPK
models. This database will also be used in Aim 2 to verify and optimize simulations of different
IVPT setups, such as different membrane types, diffusion cell types, etc. The QSARs built in
to the MPML MechDermA describing drug partitioning, diffusion and binding will be
systematically evaluated, resulting in identification of the best performing combination of
QSARs. If necessary new QSARs will be developed to improve ab initio predictions. The
verified IVPT module will be enhanced to inform the design of IVPT studies including
estimation of receptor solution solubility and LLOQ requirements. Under Aim 3, a
comprehensive series of in vitro characterization, release and permeation studies will be
conducted, focusing on four formulations of hydrocortisone (HC) and clobetasol propionate
(CP). This data will be used in Aim 4 to develop robust PBPK models and subsequently
extrapolate to the in vivo scenario, where identified literature data will be leveraged to verify
the in vivo models for healthy and diseased populations. Under Aim 5, in-house HC and CP
drug products with a modified formulation attribute will be designed and characterized. These
modified formulations will be used to challenge the PBPK models, which will verify the Model’s
ability to distinguish bio(in)equivalence. As part of this Aim, existing formulation models will be
enhanced and models for advanced release technologies such as microspheres and
liposomes will be investigated. Aim 6 deals with concurrent excipient/penetration enhancer
absorption with a particular focus on propylene glycol. Experimental data on propylene glycol
penetration from the clobetasol propionate cream (Aim 2), will be used to study concurrent
absorption and account for this using the excipient model in the MPML MechDermA.

Public health relevance
Project Narrative This project will increase the predictive performance, reliability and flexibility of the Simcyp Multi-Phase Multi-Layer Mechanistic Dermal Absorption (MPML-MechDermA) PBPK model. The MPML MechDermA recently gained regulatory acceptance of a Diclofenac sodium topical gel (Tsakalozou et al. 2021), the further verification and expansion of the model proposed here will allow similar usage for complex, multi-phase formulations including advanced drug release technologies (i.e., microspheres, liposomes). Overall, this will improve confidence in the use of PBPK modelling for assessing Virtual Bioequivalence and will ultimately allow safer, faster and more cost effective generic drug products development.